Methods Core

The University of Washington Practice-Based Suicide Prevention Research Center is a multidisciplinary center
that bridges the fields of pediatrics, family medicine, psychology, informatics, and public health. Each
discipline represented in this Center brings to the table experts in suicide health services and clinical research,
integrated behavioral interventions in outpatient medical settings, Human Centered Design, multi-phasic
optimization strategy (MOST), point-of-care Clinical Decision Support, hybrid implementation trials, innovative
suicide methods, and statistical expertise. Together, this team has developed a Suicide Care Optimization Co-
Design approach that will be used for all research projects supported by the Center. The Methods Core, co-led
by Drs. Adrian, Hallgren, Hartzler, and Cohen, will support the Signature (R01) and Exploratory (R34) projects
proposed in this application as well as eight future pilot (R03) studies. The Methods Core has two main aims:
(1) Service Products: Each research project will have its own unique contribution to improve the suicide care
pathway, together, these projects will inform a full-spectrum model that healthcare systems can implement in
its entirety or implement the components tailored to system-specific needs and (2) Scientific Inquiry: This
center will advance scientific inquiry regarding the measurement of suicide-related outcomes, understanding of
constraints affecting intervention implementation, and adaption of promising emerging methods to support
suicide care and related research across the suicide care pathway. The Methods Core will also provide
operational support, disseminate methodological advances and Center resources, and evaluate Center
research productivity and impact. These results will have a significant public health impact that addresses
NIMH priorities as well as Joint Commission, Zero Suicide, the Surgeon General's National Strategy, and
National Action Alliance for Suicide Prevention recommendations for improving suicide prevention in health
care systems and the Biden administration's 2021commitment to “advancing suicide prevention best practices
and improving non-punitive crisis response.”